Investigating the Contribution of Motor Neuronal Mitochondria to Charcot Marie Tooth Type 2D (CMT2D)

PROJECT SUMMARY
Charcot-Marie Tooth disease (CMT) is a rare, heritable, and heterogeneous peripheral neuropathy that can
affect both motor and sensory neurons. There is currently no cure or pharmacological treatments, and the
many CMT subtypes make finding common therapeutic routes difficult. Healthy mitochondria are critical for
proper neuronal function and dysfunctional mitochondria have been shown to be associated with
neurodegenerative diseases. Many subtypes of CMT have causative mutations in nuclear-encoded
mitochondrial proteins, such as MFN2, GDAP1, and COX6A1. The goal of this project is to characterize
mitochondrial morphology, function, and proteomes in CMT2D (caused by mutations in GARS), which is a
genetically bifunctional tRNA synethetase, catalyzing the addition of glycine to tRNAGly in both mitochondrial
and cytosolic translation. Mouse models of CMT2D have a cell-type specific reduction in mitochondria levels in
motor neurons, and transcription signatures indicating mitochondrial dysfunction. The long-term goal of this
project is to elucidate how perturbations in motor neuronal mitochondria are impacting the functionality of
motor neurons in CMT2D and extend these findings to related peripheral neuropathies. This proposal is novel
because it is the first to investigate neuronal compartment- and cell-type specific mitochondrial protein
expression in CMT and how changes lead to length-dependent peripheral neurodegeneration. I hypothesize
that mutated glycyl tRNA synthetase (GARS) will impact mitochondrial translation leading to altered expression
and reduced functionality of mitochondrial proteins (largely electron transport chain (ETC) complexes Aim 1 will
investigate Gars human iPSC-derived motor neurons, cultured in microfluidic devices to distinguish neuronal
compartments. Aim 2 will measure mitochondrial protein levels through cell-type specific isolation of GFP-
tagged mitochondria in Gars mice, with biochemical and immunofluorescence validation. Mitochondrial
proteomics will be conducted in a neuronal compartmental specific fashion (distal axon vs. soma), alongside
mitochondrial morphological, functional, and validation assays. Together, these experiments will not only
establish how motoneuronal mitochondria are perturbed, but also compare cell-type and compartment-specific
similarities and differences. My goals for training include (i) acquiring an experimental skillset that will enable
me to probe cellular and molecular neurobiological mechanisms, (ii) gain proficiency at implementing a robust
cell culture experimental model, and (iii) improve scientific communication and mentoring skills. These will
assist me in becoming an independent research scientist in investigating the cellular mechanisms behind
physiological phenomena in disease contexts. My graduate program, institution, and thesis mentor have
successful training records, providing me with a resource-rich environment to execute the research strategy
and achieve my training goals.

Public health relevance
PROJECT NARRATIVE Charcot-Marie-Tooth (CMT) disease is a collection of inherited peripheral neuropathies that affects ~1:2500 people, leading to weakness and sensory deficits in the hands and feet, and for which there is no approved treatment. Mitochondria provide cells energy, and many of the genes mutated in CMT patients affect mitochondrial function. Here I will combine mouse models of CMT with human cell lines engineered to carry CMT-associated mutations to investigate the contribution of mitochondrial dysfunction to CMT2D disease etiology, potentially identifying novel therapeutic strategies.